PHORA-Pulmonary Hypertension Outcome Risk Assessment

ABSTRACT
This application seeks to develop improve and expand a multi-platform clinical decision support system
(CDSS) in pulmonary arterial hypertension (PAH) for physicians, PHORA (Pulmonary Hypertension
Outcomes Risk Assessment), which can be used in adults and children to: a) guide therapeutic decisions
and b) optimize clinical trial design. We will achieve this goal by utilizing clinical trial data from several large
databases of completed trials in PAH, ongoing adult and Pediatric PAH registries and Biobanks. The proposed
aims co-create the CDSS with a multi-disciplinary group of specialties including: biomedical engineering,
advanced PAH, computer science (machine learning/data mining), human computer interaction, and palliative
care experts. Our intention is to engage all stakeholders to achieve consensus and thereby assure the
acceptance of PHORA into practice. Successful completion of this project will lay the foundation for a
prospective, multi-center META-Registry in which PHORA will be evaluated with respect to modeling best
practice interventions leading to improved long-term patient outcomes. The ultimate aim is to disseminate this
resource so as to improve the efficiency, efficacy, and cost-effectiveness of this treatment for PAH.

Public health relevance
PROJECT NARRATIVE Pulmonary arterial hypertension (PAH) is a rapidly progressive fatal disease for which there are few therapeutic options. Understanding how to predict clinical responses to available therapeutics would be a significant clinical advance in treating this disease by permitting tailored, targeted and effective first line therapies. Our continued studies seek to develop and validate a decision support tool for predicting survival in Adult and Pediatric PAH, which will allow the scientific community and patients a means to choose appropriate specific therapies based on individual risks and patient choices in order to improve survival and quality of life for our patients.